Prevention Sciences

Bold integration of biomedical and behavioral science will result in successful HIV Prevention. Our Prevention Core leadership includes Co-Directors Michelle Lally, MD, MSc and Larry Brown, MD. With a shared passion for HIV prevention and a shared vision of novel

Public health relevance
HIV is a preventable infection, and AIDS is a preventable disease; yet prevention success can be achieved only when effective biological products are combined with requisite behavioral methodologies. The Prevention Core proposes to strategically support HIV prevention efforts with a combination of biomedical and behavioral science through the provision of expert